Profiling the alcohol-naive primate cortex to understand the functional role of epigenetics in predisposing the brain to risky alcohol use

PROJECT SUMMARY
Among the six percent of active ethanol drinkers who develop an alcohol use disorder (AUD), there is
great variability in etiology and relapse rates. Early and accurate identification of individuals at risk of developing
an AUD would facilitate effective deployment of personalized interventions. Recent evidence demonstrates that
individuals with low cognitive flexibility and a predisposition towards habitual behaviors are at an increased risk
for future heavy drinking. However, the underlying molecular mechanisms driving these differences in cognition
and the accompanying higher risk for drinking remain unknown. Growing evidence suggests that an epigenetic
signature, either inherited or acquired in life, predisposes individuals to risky addictive behaviors. However,
cross-sectional studies cannot reliably identify this pre-existing risk and distinguish it from an induced effect of
chronic alcohol use. Attempts to identify biomarkers of AUD have focused on easy-access tissues, specifically
peripheral blood. While these studies are important, their ability to inform on the specific molecular mechanisms
in the brain are limited. To overcome this limitation, we conducted a longitudinal genome-wide DNA methylation
(GW-DNAm) analysis of the rhesus macaque dorsolateral prefrontal cortex area 46 (dlPFC-A46) collected before
alcohol use. The dlPFC is a component of the executive network and is critical for cognitive function and decision
making. With alcohol-naïve dlPFC-A46 samples from 11 male macaques, we identified 3,539 differentially
methylated regions (DMRs) that were associated with future ethanol drinking levels (following 12 months of
drinking). The genes mapped by these DMRs are enriched in neurogenesis, neuronal differentiation,
axonogenesis, synaptic plasticity and glutamatergic neurotransmission. These results suggest that, in an
alcohol-naïve state, the variability in DNAm signatures represents a vulnerable neural state primed for
future problematic drinking. In this application, we seek to identify more robust molecular signatures that
explain pre-existing risk for excessive alcohol consumption by increasing the sample size (n = 54), completing
cell-sorting to reduce noise from cellular heterogeneity, and including both males and females. Furthermore, we
will include functional studies to better understand the regulatory function of these DMRs and evaluate their
impact on gene expression in different cell type populations. This proposal will elucidate, for the first time, the
pre-existing neural molecular signatures priming the brain of alcohol-naïve individuals for future risk of excessive
alcohol consumption. To increase translatability, we will characterize the methylomics and metabolomics of blood
samples collected from the same subjects. In totality, this work will translate behavioral phenotypes into neural
markers of risk for AUD and hold promise for parallel discoveries in risk for other disorders involving impaired
cognitive flexibility.

Public health relevance
PROJECT NARRATIVE Alcohol use disorder is heterogeneous in etiology, severity, and response to treatment. Preliminary analysis of biopsies from the cortex of a small cohort of male macaques collected before alcohol use identified pre-existing epigenetic variability priming the brain for future problematic drinking. Here, we propose using third generation omics and functional validation together with a larger sample size - including both males and females - to identify sex-and cell type-specific molecular signatures that explain pre-existing risk for excessive alcohol consumption.